Neighborhood characteristics and neurodevelopment: Risk and protective factors, and susceptibility to later stressors and school disruption

Project Summary
Neighborhoods are an important ecological context for child and adolescent development and a social determinant of physical health, mental health, and school achievement. Research has begun to elucidate the associations between neighborhood characteristics and brain structure, function, and behavior in relation to executive function (EF) emotion regulation (ER), and emotional processing which may contribute to these short- and long- term differences in health and development. Nevertheless, there are no population-based studies that have examined the relation between neighborhood characteristics, and changes in neighborhood characteristics, with longitudinal changes in neurodevelopment to determine if differences widen, narrow, or remain stable during adolescence, a potential sensitive period. Moreover, there has been limited consideration of how associations may vary across the country. In addition, neighborhood characteristics may increase vulnerability to major stressors and changes in schooling, such as the changes that occurred in youth’s experiences during a public health disruption. These multi-dimensional changes in youth environments, stress, and schooling may exacerbate neighborhood-related differences in neurodevelopmental systems. Finally, it is important to understand resilience and the modifiable contextual factors that may protect against both neighborhood characteristics and the impact of changes in youth environments, stress, and schooling. This proposal will use the Adolescent Brain and Cognitive Development (ABCD) Study to address these questions. The ABCD Study enrolled 9-10-year-olds (n = 11,878) across 21 U.S. sites, contains multimodal measures of neurodevelopment for EF, ER, and emotional processing and rich measures of family, school, and neighborhood contexts, as well rapid measurement of the impact of a public health disruption on experiences. This study will capitalize on the staggered timing of the onset of a public health disruption in the ABCD cohort, which occurred between varying waves of data collection across participants. This creates a quasi-experimental design with the study separated into a pre-disruption and post-disruption onset phase. We will determine the association between neighborhood characteristics, and neighborhood change, and longitudinal change in brain and behavioral development, prior to a disruption (Aim 1). Second, we will examine if multi-dimensional change in youth environments, stress, and schooling overall during a public health disruption, as well as specific changes, exacerbate neighborhood related differences, with pre-disruption measures serving as controls for post-disruption measures. (Aim 2). Finally, we will elucidate the modifiable family, community and school factors that serve as moderators and foster resilience (Aim 3). This study will thus identify potential neurodevelopmental pathways related to neighborhood characteristics and changes in youth environments, stress, and schooling and identify modifiable contextual factors that are potential targets for policy and programmatic interventions to promote health and well-being and inform strategies to prevent long-term sequelae to major stressors and disruptions.

Public health relevance
Project Narrative Although recent research has found that neighborhood contexts are associated with brain structure, function, and behavior in relation to executive function (EF) and emotional functioning, central questions remain as to the role of neighborhoods in developmental change in these systems during adolescence, whether neighborhood characteristics may also increase vulnerability to multi-dimensional changes in youth environments, stress, and schooling, such as occurred during a public health disruption, and the modifiable contextual factors that may protect against adversity and foster resilience. The proposed study will capitalize on the longitudinal Adolescent Brain and Cognitive Development (ABCD) study, as well as the staggered onset of a public health disruption across waves of data collection in ABCD, which creates an innovative quasi-experimental design to address these questions. This study will thus identify potential neurodevelopmental pathways related to neighborhood characteristics and multi-dimensional changes and stressors such as those experienced during a disruption as targets for intervention as well as modifiable contextual factors that can inform policy and programmatic interventions across disciplines and the prevention of long-term sequelae to major stressors and disruptions in the future.